Telomeric Shortening, p53 and miR-34a Condition Senescence of Cardiac Progenitors

DESCRIPTION (provided by applicant): The recognition that the heart possesses a stem cell compartment that forms myocytes and coronary vessels raises the possibility that alterations in number and/or function of cardiac progenitor cells (CPCs) condition the onset of the aging myopathy. The decline in regenerative capacity of resident CPCs may dictate the accumulation of old myocytes and the cardiac senescent phenotype. The life cycle of CPCs appears to be regulated by telomerase activity and telomere length; shortening of telomeres beyond a critical length triggers cellular senescence and death. Although the role of telomere attrition in cellular aging has been documented in vitro, it remains to be determined whether loss of telomere DNA leads to organ and organism aging in vivo. Thus, our major goal is to assess whether: a) telomere shortening occurs during myocardial aging in vivo; b) CPCs with critically short telomeres undergo replicative senescence and apoptosis; and c) telomere shortening causes stem cell and myocyte aging and ultimately heart failure. We will attempt to answer these questions by employing first an animal model in which telomere erosion depends on the deletion of the RNA component of telomerase. Subsequently, we will study the telomerase-telomere axis in human CPCs (hCPCs) and establish whether telomerase activity and telomere length modulate the growth properties of these cells. Evidence in our laboratory suggests that IGF-1 prevents telomere attrition and enhances telomerase activity while Ang II promotes oxidative stress in hCPCs. Therefore, IGF-1 receptor (IGF-1R) and Ang II receptor 1 (AT1R) will be employed to isolate hCPCs with long and short telomeres, respectively. The function of IGF-1R and AT1R in hCPCs may be mediated by their opposite effects on the expression and activity of p53; p53 is expected to be critically involved in hCPC senescence. Whether p53-responsive genes dictate hCPC senescence and cardiac aging is currently unknown. We will focus on the interaction between p53, miR-34 and miR-34 target genes; miR-34 is a downstream effector of p53 and is proposed to be an important determinant of CPC and cardiac aging. PUBLIC HEALTH RELEVANCE: Senescence of cardiac progenitor cells is a critical determinant of the aging myopathy. A new approach is proposed here for the identification of progenitor cells which may have a significant capacity to divide and form a large number of cardiomyocytes. If successful, this strategy may have important implications for the management of human heart failure in the elderly.

Public health relevance
07. Project Narrative Senescence of cardiac progenitor cells is a critical determinant of the aging myopathy. A new approach is proposed here for the identification of progenitor cells which may have a significant capacity to divide and form a large number of cardiomyocytes. If successful, this strategy may have important implications for the management of human heart failure in the elderly.